An Immersive Experience in Medical Genomics

Project Summary Next generation sequencing (NGS) has transformed the field of genomics, bringing it to the forefront of healthcare, however the rapid pace of technological developments in the field challenges even field experts to stay current. The successful implementation of genomics into clinical practice requires much more than a superficial understanding of the technology. The proposed course, An Immersive Experience in Medical Genomics is designed for a broad audience of clinicians seeking a strong foundation in genomics, and will be structured to facilitate collaboration and crosstalk across disciplines. It builds upon the currently funded program developed at Children's Mercy Hospital (CMH) that uses a multimodal educational approach including Personal Genome Education Testing (PGET) to engage participants in genomics and precision medicine. The central goal of the proposed course is to facilitate the implementation of genomic medicine into all aspects of clinical practice. We will accomplish this goal through the following specific aims: 1) create a flexible teaching model to optimize genomic education through a combination of well-designed e-learning modules, lectures, case-based discussions, and hands on workshops, 2) educate course participants on special ethical, legal, and social implications (ELSI) of genomic testing, 3) to promote the integration of clinical genomic research into traditional clinical practice. Short and long-term impacts for purposes of curriculum modification and impact will be collected, with results distributed through scholarly activities (presentations and publications). The proposed course will enable The Center for Pediatric Genomic Medicine (CPGM) to share our translational genomic expertise with 250 clinicians, committed to the integration of genomic guided precision medicine into clinical practice, over 5 years.

Public health relevance
Project Narrative Next generation sequencing (NGS) has transformed the field of genomics, bringing it to the forefront of healthcare, however the rapid pace of technological developments in the field challenges even field experts to remain current. The successful implementation of genomics into clinical practice requires much more than a superficial understanding of the technology. The proposed course, "An Immersive Experience in Medical Genomics" is designed for a broad audience of clinicians seeking a strong foundation in genomics, and will be structured to facilitate collaboration and crosstalk across disciplines.